Optimizing a Digital AEP Risk Intervention with Native Women and Communities

Over 3.3 million US women per month are at risk for Alcohol-Exposed Pregnancy (AEP). Prenatal alcohol
exposure can cause lifetime costly intellectual and physical disabilities in children. Risk for AEP is greater
among Native Americans, because rates of unintended pregnancy and binge/heavy drinking are inequitable
between Native women and the general population. AEP counseling interventions for Native women are
efficacious, but too costly to sustain. Digital interventions increase the reach of evidence-based behavioral
interventions while reducing cost. This project will tailor and optimize the first digital AEP intervention, CARRII,
piloted in a general population of women with AEP risk, for Native women. Guided by the Multiphase
Optimization Strategy (MOST), we will systematically test a Native-tailored version of CARRII with candidate
novel components to develop an optimized intervention for Native women at risk of AEP. The overarching goal
of this R61/R33 proposal is to determine the optimal combination of novel intervention strategies to include
with CARRII (tailored for Native women) that maximizes digital intervention efficacy at feasible cost for Native
communities. In R61 Aim 1, we will identify needs for a digital intervention for AEP risk reduction for Native
women, determine the best strategies for their engagement, evaluate and tailor CARRII intervention
components for Native women, and deploy CARRII and new intervention components on a platform that is
accessible on any device. In R61 Aim 2, we will tailor 5 new candidate intervention components that vary in
automation and hypothesized impact on AEP risk behavior, and determine their costs and short-term effect
sizes on alcohol and contraception. The 5 candidates are: repeated timeline follow-back AEP risk interviews,
monthly pregnancy testing, digital training on skills for safer sex and reduced drinking, automated text
messaging to prompt use of safer sex and reduced drinking skills, and access to an anonymized participant
community message board. We will test each component in 6-week pre-post trials with 50 Native women to
assess independent effects on drinking and contraception while considering practical aspects such as
frequency and duration of contact with participants and costs of each component. Achieving R61 milestones
will permit progression to the R33 phase. In R33 Aim 3, we will conduct a large 3-month factorial experiment
with 512 participants. This design will identify the optimal intervention that efficiently balances AEP risk
reduction with community-informed sustainable cost. We will conduct exploratory analyses of mediation/
moderation and identify study feasibility metrics (rates of Native women with AEP risk, and completing study
recruitment, baseline, intervention, and follow-up vs. dropout) for a subsequent RCT. This project will be the
first to systematically optimize a digital AEP intervention tailored for Native women at acceptable costs. The
project will prepare the team for the first nationwide RCT of an optimized, sustainable digital AEP intervention
tailored with and for Native women at risk of AEP to reduce AEPs in this high risk subpopulation.

Public health relevance
Alcohol-exposed pregnancy (AEP) can cause lifetime intellectual and physical disabilities, including Fetal Alcohol Spectrum Disorders, but AEP can be prevented with behavioral interventions. This project will be the first to systematically optimize a previously tested digital behavioral intervention, CARRII, for Native women at risk for AEP. The project will generate a new digital AEP intervention for Native women that could sustainably reduce AEPs in this high-risk subpopulation at acceptable costs.